Mechanisms Underlying Sexual Minority Health Disparities in the United States

Project Summary/Abstract
Families headed by sexual and gender minorities are a growing segment of the population, yet sexual and
gender minority health disparities in areas including self-rated health, chronic conditions, health behaviors, and
depression persist. Minority stress has been implicated as a key cause of health problems, and family
functioning, emotion regulation, couple-level minority stress, and community contexts have been identified as
potential mechanisms underlying these associations. Contemporary theoretical models have yet to be tested
due to a lack of data, and further, this lack of data has made studies of the intersection of racial and ethnic
minority stress with sexual and gender minority stress difficult. This project will produce the first population-
representative, multi-method, fully-powered study of cohabiting and married sexual and gender minorities and
their partners, and a comparison sample of cis-gender individuals in different-gender unions. Aim 1. Evaluate
whether and how family functioning (e.g. relationship quality) mediates the negative effects of stress due to
discrimination on physical and mental health and health behaviors. Aim 2. Using an experience sampling
method embedded in a time-diary, examine 1) the mediating role of emotion regulation, and 2) dyadic stress
processes in the association between stress and subsequent health behaviors and time-use among same-
gender couples. Aim 3. Investigate the association between community-level factors including economic
disadvantage, access to healthcare, and the sexual and gender minority political climate (i.e. state employment
protections) and sexual and gender minorities’ physical and mental health and health behaviors. Aim 4.
Determine race and ethnic health gaps among sexual [and gender] minorities and evaluate potential protective
factors that may minimize these gaps. We will recruit 2690 US adults aged 18 to 60 who are cohabiting or
married to same- and different-gender partners, along with their partners. The sample will include an
oversample of respondents of color. Population-representative Gallup samples afford a unique and efficient
opportunity to study sexual and gender minorities who are in unions via targeted sampling. Using a mobile
phone application platform, we will also collect time-diary and experience sampling method data. The primary
significance of this project is 1) the identification of family functioning and emotion regulation as mediators of
sexual and gender minority stress due to stigma and discrimination and poor physical and psychological health
and health behaviors, and 2) the collection of dyadic data that will elucidate dyadic minority stress processes.
The proposed research is innovative because it is the first contemporary, population-representative study of
sexual and gender minority health that includes family functioning, emotion regulation, and dyadic data and an
oversample of racial and ethnic minorities. These data will help researchers better understand how to improve
the health of sexual and gender minorities by illuminating potential mechanisms underlying health disparities.
Data will be available to scholars across the world through ICPSR and the American Heritage Time Use Study.

Public health relevance
Project Narrative The proposed research is relevant to public health because 1) the identification of family functioning and emotion regulation as mediators of sexual and gender minority stress due to stigma and discrimination and poor physical and psychological health and health behaviors, 2) the collection of dyadic data critical to testing dyadic minority stress processes, and 3) the examination of the intersection of sexual and gender minority stress and racial and ethnic minority stress, are ultimately expected to lead to new evidence-based interventions and policies designed to improve adult and child wellbeing across American family contexts. Overall, the primary positive impact will be evidence that will be applicable to clinical and community settings to set adults and children in the families of sexual and gender minorities on successful developmental trajectories. Thus, the proposed research is relevant to that part of the NICHD's mission that all Americans are able to develop to their full capability so that their lives, and intimate relationships, may be healthy, gratifying, and long.